Regulation of the extracellular HSP90 chaperone machinery

PROJECT SUMMARY
Although secreted molecular chaperone heat shock protein 90 (eHSP90) has been implicated in tumor cell
invasion through binding and stabilizing extracellular matrix protease client MMP2, our limited understanding of
the regulatory mechanisms that control the eHSP90 chaperone system is a major drawback for designing
successful HSP90-targeted therapies. Our long-term goal is to develop therapeutic strategies that prevent
tumor cell invasion by targeting the extracellular HSP90 chaperone machinery. Our overall objective is to
elucidate how eHSP90 and its regulators are mechanistically modulated, individually and collectively, and in
the presence of their extracellular inhibitors. Our central hypothesis is that extracellular ATP, and tyrosine
phosphorylation of eHSP90 co-chaperone TIMP2, modulate the chaperoning of client MMP2, and affect
HSP90 binding to extracellular inhibitors. This hypothesis is based on our recent published work and
preliminary studies showing that eHSP90 binds and hydrolyzes ATP, and that co-chaperone TIMP2 enhances
HSP90 binding to ATP and its pharmacologic inhibitors. Our rationale is that by elucidating mechanisms of
eHSP90 chaperone regulation, we will design better therapies for diseases that implicate the eHSP90
machinery. We plan to test our central hypothesis by pursuing the following three specific aims: 1) Investigate
the role of ATPase activity in the regulation of extracellular HSP90 (eHSP90); 2) Determine the impact of
tyrosine phosphorylation of TIMP2 on its co-chaperone function; and 3) Elucidate the role of TIMP2 in
enhancing eHSP90 binding to extracellular inhibitors. Under the first aim, approaches to be used are already
established in PI's laboratory and include purification of intracellular and extracellular HSP90 from human cell
cultures, isothermal calorimetry to determine affinity towards an ATP analog, ATPase assays to measure
ATPase activity, enzyme kinetics to determine proteolytic activity, and in vitro and in vivo protein-protein
interactions in the presence and following depletion of extracellular ATP in genetic knock out cell cultures.
Under the second aim, phosphomimetic or non-phosphorylatable TIMP2 mutants designed in the PI's
laboratory will be used, CRISPR knock out cell lines for c-Src kinase, TIMP2 and MMP2 will be employed for
protein-protein interactions and to determine impact on MMP2 activity. Under the third aim, the role of TIMP2,
non-phosphorylatable and phophomimetic mutants in enhanced binding of eHSP90 to its extracellular
inhibitors will be evaluated in drug binding assays performed in vitro and extracellularly in vivo, using human
cell lines and siRNA technology. The impact of TIMP2, and eHSP90 inhibitors on MMP2 mediated proteolysis
will be evaluated in matrix degradation studies. The research approach is innovative, in the PI's opinion,
because it represents a new and substantive departure from the status quo by shifting focus towards targeting
chaperone-regulated extracellular pathways. The proposed research is significant because, it is expected to
provide insight on the basic extracellular regulatory elements that support mechanisms of tumor cell invasion.

Public health relevance
PROJECT NARRATIVE Cell invasion through the basement membrane barrier is one of the early phases in the multistep process of tumor cell dissemination and indicative of disease progression. The proposed research is relevant to public health because elucidation of regulatory mechanisms of cell invasion will ultimately increase our understanding of diseases that depend on this behavior to progress. Thus, the proposed research is relevant to NIH's mission because it will yield fundamental knowledge that will assist in the improvement of human health and translate into new treatments for invasive diseases including neurodegenerative, cardiovascular and cancer.